UAB-UCSD O'Brien Center for Acute Kidney Injury Research

Project Summary
Kidney diseases in general and acute kidney injury (AKI) in particular impose substantial morbidity
and mortality; these remain unabated in recent decades despite concerted efforts to reduce both. The
overall mission of the University of Alabama at Birmingham (UAB)-University of California San Diego
(UCSD) O'Brien Center for AKI Research is to improve the health of patients by fostering research
specifically targeted to the prevention and treatment of AKI and its complications. To achieve this mission,
this Center crosses institutional boundaries and research fields to harness the momentum and ingenuity of
ongoing pre-clinical and clinical research in both institutions. The following aims are proposed: i) facilitate
hypothesis-driven research through shared core facilities and leverage these technologies into new projects
and collaborations, (ii) foster relevant interactions among UAB-UCSD investigators from different disciplines
and extend these interactions to investigators from multiple institutions, (iii) provide, through the Biomedical
Research Cores, a Pilot and Feasibility Grants (PAF) Program, and attract new and established
investigators to AKI research by capitalizing on our research cores and infrastructure, (iv) build upon the
progress during the last cycle by responding to the evolving needs of our investigators, (v) administer an
Enrichment Program that delivers outstanding training and education across the continuum of research
activity, and (vi) leverage substantial institutional commitments (>$1.5 million) to advance these aims.
Three complementary Cores will continue to integrate existing intellectual and technological
resources of UAB and UCSD and provide a defined set of services to facilitate investigator-initiated AKI-
related research. The Cores include: 1) Resource for Clinical Studies of AKI (clinical research, registry and
biorepository including human kidney tissues); 2) Resource for Pre-Clinical Studies of AKI (animal models,
small animal imaging and physiology); 3) Bioanalytical Core (bioenergetics, biomarkers, small molecule
analysis). A Biostatistical Resource will provide support for the cores and pilot projects. The Center also
includes an active and productive PAF program designed to attract new investigators into the field and yield
a high return on investment in terms of extramural funding and publications. In the prior 4 years of funding,
the Center has galvanized our research community and created a robust collaborative environment
particularly for AKI research integrating two institutions and resulting in 220 publications. The Internal
Research Base includes 100 investigators (from UAB and UCSD) with NIDDK funding of $9.6 million in
annual direct costs and 88 investigators from other institutions that form an Extended Research Base.
Twelve pilot awardees were funded, and we propose to fund 3-4 pilots/year in this renewal cycle. The
Center will continue to promote a seamless integration of expertise and resources at both institutions for
innovative and productive research needed for the translation of new insights into novel therapies for
patients with AKI.

Public health relevance
Project Narrative Acute kidney injury (AKI) is a major cause for morbidity and mortality in hospitalized patients and is being increasingly recognized as a cause for chronic kidney disease. AKI doubles the length of stay in the hospital, increasing health care resources. The UAB-UCSD O'Brien Center has brought together a team of investigators to serve unmet needs of our investigator base and to fill the gaps in knowledge in the field of AKI and AKI-related research.